Mechanisms of resistance to endocrine therapy in ER positive breast cancer

PROJECT SUMMARY/ABSTRACT: MECHANISMS OF RESISTANCE TO ENDOCRINE THERAPY
IN ER+ BREAST CANCER
Estrogen receptor positive (ER+) breast cancer is the most common subtype of breast cancer, but ~20% of ER+
tumors recur during or following adjuvant endocrine therapy, accounting for ~50% of breast cancer deaths in the
US each year. The CDK4/6 inhibitors palbociclib, ribociclib and abemaciclib have been recently approved in
combination with endocrine therapy for the treatment of metastatic ER+ breast cancer. However, as for other
cancer targeted therapies, all patients with metastatic disease on CDK4/6 inhibitors eventually progress,
suggesting the development of mechanisms of acquired drug resistance that remain to be discovered. We
propose a continuation project where we will investigate the effect of aberrant FGFR signaling on resistance to
endocrine therapy in combination with CDK4/6 inhibitors in patients with ER+ breast cancer with the following
aims:
 Aim 1: To elucidate the mechanisms by which FGFR1 amplification confers resistance to the combination
of fulvestrant and CDK4/6 inhibitors in ER+/FGFR amplified breast cancers
 Aim 2: To conduct a phase Ib and a randomized phase II trial of the ER downregulator fulvestrant plus
palbociclib ± the pan-FGFR inhibitor erdafitinib in patients with ER+/FGFR-amplified metastatic breast cancer
 Aim 3: To discover mechanisms of drug resistance in organoids derived from tumors progressing on CDK4/6
inhibitors. These will include: 1) tumors from patients progressing on treatment with fulvestrant/palbociclib ±
erdafitinib in Aim 2, and 2) tumors from breast cancer patients on standard-of-care therapy with CDK4/6
inhibitors
To our knowledge, this is the first time an FGFR inhibitor will be tested in combination with ER and CDK4/6
inhibitors in patients with breast cancer harboring FGFR amplification. A positive outcome of this clinical trial
may provide women with FGFR-amplified/ ER+ breast cancer with a novel treatment option that does not include
cytotoxic chemotherapy. Increased efficacy of the combination of fulvestrant, palbociclib and erdafitinib will also
accelerate the development of FGFR inhibitors. We seek to identify biomarkers predictive of response to the
combination that can be used in trials in appropriately selected patients with ER+ metastatic breast cancer. In
addition, the comprehensive molecular analysis of organoids from cancers progressing on treatment provides
an opportunity for the unbiased discovery of novel molecular mechanisms of drug resistance. These
mechanisms, in turn, may represent actionable molecular targets that can be the focus of future drug discovery
efforts and/or translational/clinical investigation in breast and other FGFR-dependent cancers. As such, the aims
proposed herein may contribute to progress in the eradication of ER+ breast cancers.

Public health relevance
PROJECT NARRATIVE: MECHANISMS OF RESISTANCE TO ENDOCRINE THERAPY IN ER+ BREAST CANCER This project is a continuation project to investigate the effect of aberrant FGFR signaling on resistance to endocrine therapy in combination with CDK4/6 inhibitors in patients with ER+ breast cancer. The aim is to discover predictive biomarkers for identifying patients for trials with fulvestrant/palbociclib ± an FGFR inhibitor.